Structural insights into the functional regulation of O-GlcNAcase

In response to the “Research Supplements to Promote Diversity in Health-Related Research (PA-23-
189)”, I am applying for the Diversity Supplement award to support an underrepresented minority
predoctoral student to obtain personalized mentoring and training on research in protein glycosylation and
drug discovery, and to develop essential intellectual and professional skills to achieve her goal in biomedical
research career path.

Public health relevance
Project Narrative Human O-GlcNAcase (OGA) is an essential enzyme, and its dysregulation has been detected in numerous diseases including cancer. This application aims to elucidate novel structures and mechanisms underlying OGA’s complex regulations and pave the way for development of more selective and effective therapies for challenging diseases.